Development of a Rapid Antibiotic Susceptibility Test Capable of Detecting Heteroresistance

The World Health Organization (WHO) has highlighted antibiotic resistance as one of the greatest medical
challenges of the 21st century. Without new antibiotics, it is predicted that antibiotic resistant infections will cause
10 million annual deaths worldwide by the year 2050 (surpassing cancer). These infections are poised to negate
many advances of modern medicine that rely on antibiotics. Thus, choosing effective antibiotics based on
bacterial susceptibilities would provide the greatest therapeutic benefit.
One form of resistance that is overwhelmingly undetected is heteroresistance, in which a minor subpopulation
of bacterial cells is phenotypically resistant. These resistant cells rapidly expand in the presence of an antibiotic
and thus can cause treatment failure. As heteroresistance is common (>25% of antibiotic-bacteria combinations),
detecting heteroresistance is critical to address the growing crisis of antibiotic resistance. Indeed, it was recently
demonstrated that knowledge of heteroresistance can be used to guide successful combination therapy, and
can thus even treat pan-resistant bacteria.
Unfortunately, clinical susceptibility tests lack the resolution to identify heteroresistance, and the laboratory test
for heteroresistance is time consuming and slow. Further, the next-generation susceptibility tests currently under
development are largely focused on rapid diagnostics performed on a small number of cells, making detection
of rare cells impossible. Developing a new susceptibility test is further complicated by the requirements of the
clinical microbiology laboratory; to be adopted, a susceptibility test must require minimal manual labor, work
robustly, and be inexpensive – properties that are often at odds with high sensitivity. Based on these issues,
there is broad agreement that a new technological approach is required.
Here the development of a new, more sensitive susceptibility test using interferometry to measure bacterial
population topography is proposed. The use of interferometry to measure topography has no precedence in
antibiotic susceptibility testing, and little precedence in biomedical research. However, its commonly used in
physical sciences as it is rapid, inexpensive, robust, doesn’t require dyes or stains, and provides super-resolution
measurements of topography. Preliminary results demonstrate that interferometry has the resolving power to
rapidly detect heteroresistance and distinguish it from susceptibility. Our interferometry-based approach is a
substantial improvement over clinical susceptibility tests that cannot detect heteroresistance, research laboratory
tests that can detect heteroresistance but are too slow for clinical application, and traditional topographic imaging
approaches, e.g. confocal microscopy, that are expensive and lack the resolving power to distinguish
heteroresistance from susceptibility. Building off our promising preliminary results, this proposal will determine
the underlying biophysics relating bacterial topography to death and reproduction. This work is pivotal to reliably
convert topography into susceptibility profiles across a broad range of clinically relevant bacteria and antibiotics.

Public health relevance
The rise of antibiotic resistance threatens to negate many advances of modern medicine which rely on antibiotics, in part because a common form of resistance, heteroresistance, is undetectable. We propose to develop a new approach to susceptibility testing, built on interferometric measurement of topography, which is able to detect heteroresistance, and is rapid, robust, and inexpensive. This new technology will help clinicians avoid treatment failure, suggest new combination therapies, and in the long term may be applied to other biomedical problems that involve unrestrained cellular reproduction, such as cancer.